TRIO Administrative Core

The North Carolina Kidney, Urology, and Hematology Training, Research, Innovation, and Outreach Program
(henceforth referred to as TRIO) aims to create an innovative, integrated, interactive and diverse training and
mentoring program in KUH diseases that is demographically representative of the state of North Carolina. The
goal of the Administrative Core is to provide the infrastructural support, communication, collaboration, and
connectivity between the different institutions and cores, including access to resources such as program
coordinators and the organization of virtual and in-person meeting places. This will allow TRIO to create a holistic
and fertile training substrate for KUH science and for professional and personal life skills that will help our people
become leaders and innovators who will transform KUH science and patient care. We plan to accomplish this by
(a) creating an organizational and governance structure that allows for collaborative leadership and
communication between the participating institutions and the implementing cores; (b) developing a real-world,
evidence-based, and streamlined trainee selection and evaluation system for TRIO; and (c) organizing one of
the annual face-to-face meetings for all awardees of the KUH U2C-TL1, while also working closely with the
Networking Core to facilitate the programming and platforms needed to create, train, and retain a rich and diverse
pipeline of KUH trainees. In summary, the Administrative Core aims to seamlessly facilitate the TRIO program
by optimizing operational efficiency (the cost of doing translational science) and translational efficiency (the
speed of discovery and implementation science). Indeed, if we envision TRIO as a train, with the railcars
representing the different institutions and cores, then the Administrative Core would be the greased couplings
between the railcars allowing the entire train to travel smoothly.